CLINICAL METABOLISM CORE

The Yale-DRC Clinical Metabolism Core provides comprehensive support for investigators conducting clinical investigations of human diseases of metabolism such as diabetes and obesity. The primary emphasis of this core is to provide analytical resources for patient-oriented studies utilizing stable isotopes to determine metabolic flux at the whole body and tissue specific levels. Secondarily, the core also makes its analytical resources available to researchers utilizing rat and cell models of human metabolic diseases. Stable isotopes offer unique advantages over traditional radioisotopic methods for assessing substrate turnover in humans as they do not expose subjects to ionizing radiation and they provide positional isotopomer information that can be used to assess flux through critical metabolic pathways. The major limitation to the use of stable isotopes by the clinical investigator is the need for sophisticated and expensive instrumentation and highly skilled expertise for instrument operation and for data analysis and interpretation The Yale-DRC Clinical Metabolism Core removes these obstacles by providing the personnel and resources needed for the extraction, purification, derivatization, and instrumental analysis needed to determine the concentrations and isotopic enrichments of metabolites in plasma, urine, or tissues. This core measures the isotopic (e.g., [2]H, [13]C, [5]N, and [18] 0) enrichment and concentrations of over 140 intermediary metabolites by GC-MS, LC-MS/MS, and NMR for the calculation of turnover of carbohydrates, lipids, and proteins. The primary purposes of the Yale-DRC Clinical Metabolism Core are to: 1) make GC-MS, LC-MS/MS, and NMR analyses available to DRC members, 2) avoid duplication of costs associated with personnel and instrumentation, 3.) provide standardized protocols to insure consistent and accurate sample analysis, and 4) assist Yale-DRC researchers in the design and interpretation of experiments utilizing stable isotopes for measurement of metabolic flux.

Public health relevance
RELEVANCE (See instructions): The Yale-DRC Clinical Metabolism Core serves as a unique resource in providing both intramural and extramural researchers access to state-of-the-art analyses for measurements of stable, non radioactive, isotopes of metabolites obtained from patients with diabetes and other metabolic diseases, which in turn provides new insights into mechanism of disease and new therapies.